Medication Adherence and Cardio-Metabolic Control Indicators among Adult American Indians Receiving Tribal Health Services

Project Summary/Abstract
American Indians (AIs) have the highest prevalence of type 2 diabetes (T2D) of any racial or ethnic group and
experience high rates of co-morbidities such as obesity, cardiovascular disease (CVD), and chronic kidney
disease (CKD). Uncontrolled cardio-metabolic risk factors--insulin resistance resulting in impaired glucose
tolerance, dyslipidemia, and hypertension (HTN)--increase mortality risk. Mortality is significantly reduced by
glucose- and lipid-lowering, and antihypertensive medication adherence. Medication adherence is low among
AIs living in non-Indian Health Services (IHS) healthcare settings. Virtually nothing is known about the nature
and extent of medication adherence among reservation-dwelling AIs who primarily receive their medications
without cost from IHS/tribal facilities. Electronic health records (EHR) offer a rich but underutilized data source
about medication adherence and its potential to predict Cardio-Metabolic Control Indicators (C-MCI) such
as HbA1c, LDL-C (Low Density Lipoprotein), SBP (Systolic Blood Pressure). With the support of Choctaw
Nation of Oklahoma (CNO), we will address this oversight by using EHR data generated by this large, state-of-
the-art tribal healthcare system to investigate C-MCI. The objective of our R01 application is to characterize
the relationships among medication adherence (antihypertensive, glucose- and lipid-lowering drugs) and C-
MCI (HbA1c ≤7%, LDL-C <100 mg/dL, and SBP <130 mm Hg), patient demographics (e.g., age, sex, SDOH,
residence location) and co-morbidities (e.g., CVD, BMI>30, CKD) as well as the relationship of each C-MCI
with patient demographics and co-morbidities from the tribe's EHR (2018-2021) for the 5,970 CNO
patients who have T2D. Employing machine learning techniques, we will develop models to predict future
(2019-2021) C-MCI based on the previous year medication adherence, patient demographics, co-
morbidities, and common labs (e.g., lipid panel). Lastly, key informant interviews will explore facilitators of
and barriers to medication adherence within the context of local social determinants of health (SDOH) that are
not available in the EHR. Our specific aims are to: (1) Determine the bivariate relationships between (a)
medication adherence and C-MCIs, demographics, and co-morbidities; (b) each C-MCI and demographics and
co-morbidities; (2) Develop machine-learning models (e.g., random forest, nearest neighbors, others) for
predicting future (2019-2021) C-MCI from the previous year medication adherence, demographics, co-
morbidities, and common labs; and (3) Identify facilitators of and barriers to medication adherence within the
context of SDOH, EHR-derived medication adherence (PDC) and C-MCI (at target, above target, and for
HbA1c uncontrolled). We will share our findings with CNO leaders and other stakeholders, who will guide the
translation of the results into recommendations for evaluating T2D management and complication prevention
programs. Our findings will yield insights to improve medication adherence and C-MCI among AIs, consistent
with CNO's State of the Nation's Health Report 2017 goal of reducing T2D and its complications.

Public health relevance
Project Narrative Our long-term goal is to reduce type two diabetes (T2D)-related health disparities within Choctaw Nation of Oklahoma (CNO) communities and prevent future complications such as cardiovascular disease and hypertension. Toward that goal, we propose to analyze four years of electronic medical record data generated by a large, state-of-the-art tribal healthcare system to investigate the relationship between medication adherence and cardio-metabolic control indicators (C-MCI), to develop models that predict future C-MCI, and identify facilitators to and barriers of medication adherence. Our results will yield insight to improve medication adherence and C-MCI among American Indians, consistent with CNO’s State of the Nation’s Health Report 2017 goal of reducing T2D and its complications and to improve C-MCI among CNO patients and other American Indian communities based on future research with data from additional tribes.